Pilot Feasibility of DESCANSO: Cognitive Behavioral Therapy for Latino Cancer Patients to Treat the Symptom Cluster Depression, Insomnia and Fatigue

PROJECT SUMMARY
Symptoms of depressed mood, insomnia, and fatigue (DIF) frequently co-occur in cancer patients and Latinos
report higher symptom burden than non-Latino white cancer patients. When cancer patients experience these
symptoms as a cluster, they lead to more severe burden and poorer quality of life, than do the symptoms
individually. Notably, the onset of one symptom can trigger others in this cluster,6 underscoring the importance
of treating initial symptoms (e.g., insomnia/fatigue) to prevent the onset of others (e.g., depressed mood). This
proposal aims develop and pilot a CBT intervention, DESCANSO (Depresión/Depression, Cansancio/Fatigue,
and Sueño/Sleep; Rest in English) to treat the DIF cluster in Spanish speaking Latino cancer patients. This
study will be supported by a strong collaboration of clinics in New York (NY), and Puerto Rico addressing local
and national disparities in availability of symptom management interventions. Our overall goal is to adapt,
refine and pilot the DESCANSO intervention using the ORBIT model for developing behavioral treatments, and
the Ecological Validity Framework for cultural adaptation of interventions. Our specific aims are: 1) Refine
(culturally adapting) the intervention (DESCANSO) with CBT strategies to treat insomnia, depression,
and fatigue (DESCANSO) in Latino patients; and 2) Determine the feasibility of DESCANSO via
telehealth and further refine the intervention. We will conduct an open pilot followed by a randomized
feasibility pilot with 100 Latino cancer patients (50 from New York and 50 from Puerto Rico) randomized to two
arms: 1) DESCANSO or 2) Enhanced usual care. DESCANSO will be the first culturally adapted symptom
management intervention to treat cancer-related depression, insomnia, and fatigue in Spanish speaking Latino
patients.

Public health relevance
PROJECT NARRATIVE PUBLIC HEALTH RELEVANCE: The proposed study is relevant to public health because it addresses the critical lack of cancer symptom management behavioral interventions for the Spanish-speaking population. The symptoms of depressed mood, insomnia, and fatigue (DIF) often occur concurrently in cancer patients and Latinos frequently report higher symptom burden than other cancer patients. The goal of this study is to adapt, refine, and pilot a CBT intervention: DESCANSO, which will be the first culturally adapted symptom management intervention for Latinos to treat the DIF cluster.